Research Symposia at the Annual Convention of the Hearing Loss Association of America

PROJECT SUMMARY
The Hearing Loss Association of America (HLAA) is the nation's largest organization representing people with
hearing loss. The HLAA Convention, held annually, draws a broad national audience and is key to achieving
HLAA's mission "to open the world of communication to people with hearing loss by providing information,
education, support and advocacy." Since 1994, each HLAA Convention has featured a Research Symposium
that covers cutting-edge scientific topics relevant to adults with hearing loss. These symposia are distinctive
because they are geared toward educating the hearing loss public about research. Often this is information
that people with hearing loss cannot get anywhere else. However, many members of the HLAA community
lack the time and resources to attend the convention. HLAA seeks a renewal of NIDCD support to continue to
bring the Research Symposia to a broader audience, by producing high-quality captioned/ASL interpreted
videos of the symposium talks and disseminating them. We aim to (1) Organize and present a Research
Symposium at each HLAA convention, featuring a panel of top-tier scientists and clinicians, using presentation
formats that are accessible to attendees and others with hearing loss; (2) Harness multimedia and other
approaches to offer the content of the Research Symposia to those who cannot attend the HLAA Convention in
person, including HLAA members, people with hearing loss and their families, and the general public, and (3)
Improve hearing loss research by promoting engagement and dialogue between scientists and the hearing loss
community. Although most R13 applications are submitted by scientists and scientific or professional
organizations seeking to engage with fellow scientists, this application is innovative in that it is submitted by a
robust and engaged patient organization that seeks to disseminate information about scientific research to its
members and the wider public.

Public health relevance
PROJECT NARRATIVE Hearing loss affects an estimated 48 million Americans. This project aims to spread information about hearing loss research by supporting the convening of a high quality, communication-accessible Research Symposium at each Hearing Loss of Association of American (HLAA) annual convention and disseminating professionally edited videos of the symposia to the wider community of people with hearing loss and their families, and the general public. This will allow a wide audience will be able to be engaged in the science underlying this key public health issue.